Developing and piloting an intervention to reduce HPV vaccination disparities in rural adolescents

ABSTRACT
The Centers for Disease Control and Prevention (CDC) recommends initiating human papillomavirus (HPV)
vaccination at ages 11-12 to confer protection against anogenital and oropharyngeal cancers, though it can be
started as young as age 9. Two doses by age 13 is considered “up-to-date” (UTD), i.e. protected before the
onset of sexual activity. Nationally, UTD coverage was only 62% in 2021. In North Carolina (NC), a largely
rural state, UTD HPV vaccination coverage is only 47% in rural adolescents. Novel approaches are
needed to alleviate barriers to HPV vaccination coverage in rural areas, where adolescents may have less
access to health care or a pediatrician who routinely recommends HPV vaccination. Recommending HPV
vaccination at age 9 could increase UTD coverage in rural adolescents by allowing earlier completion of the
series and more time to achieve UTD coverage, promoting maximal and timely HPV prevention. Achieving
parity in rural HPV vaccination rates can greatly reduce urban-rural cancer disparities, including
cervical cancer. The goals of the proposed K01 project are to 1) define optimal systems for recommending
HPV vaccination at age 9 years in rural NC clinics; 2) assess acceptability and appropriateness of age-9
vaccination among rural caregivers; and 3) conduct a hybrid effectiveness-implementation study of age-9 HPV
vaccination in rural clinics. Specific Aim 1 will collaborate with health care personnel in rural clinics to
measure appropriateness and acceptability of age-9 HPV vaccination, identify opportunities for clinic-based
interventions to promote it, and incorporate these insights into a preliminary intervention plan. In Specific Aim
2, we will gauge rural caregivers’ acceptability of age-9 HPV vaccination for their children, and modify the
intervention plan as needed to maximize acceptability. Finally, Specific Aim 3 will pilot the intervention in four
rural clinics, using electronic medical records to measure UTD HPV vaccination coverage in a cohort of 9-
year-old patients over two years. My technical skills in study design and data analysis will be
complemented by extensive training in clinical research and implementation science to successfully
complete this project, relying on mentorship from experts in pediatric and adolescent health care,
implementation science, rural health, development and evaluation of clinical interventions, and research with
health care personnel. By establishing collaborative relationships with clinic research networks, understanding
the key factors associated with rural health disparities, and becoming adept at developing, implementing, and
measuring evidence-based interventions, my research career promises to increase vaccination behaviors in
areas that are most vulnerable to infections and their consequences. In addition, I will become a well-rounded
and nimble vaccine researcher, studying myriad health areas that could benefit from the introduction of novel
vaccines or improved delivery of existing vaccines. This training will prepare me to lead R01-funded studies,
including large scale clinical trials to reduce health care disparities in underserved areas.

Public health relevance
PROJECT NARRATIVE Human papillomavirus (HPV) vaccination is a critical cancer prevention intervention, but adolescents in rural areas of the United States have lower vaccination rates compared to their urban counterparts. We hypothesize that recommending HPV at the earliest possible opportunity (i.e. age 9, as compared to the current standard of 11-12 years) and aligning HPV vaccination with annual well-child visits can increase timely HPV vaccination, particularly in rural areas where receipt of primary care and pediatric care are less convenient and accessible to patients. We propose 1) to develop an acceptable and feasible clinic-based intervention that promotes recommending HPV vaccination to 9-year-old patients; 2) incorporate qualitative insights from caregivers into the intervention plan to minimize caregiver hesitancy; and 3) to pilot this intervention in four rural clinics in North Carolina to assess the hybrid effectiveness-implementation of the intervention under real-world, pragmatic conditions.